Structure, antigenicity, and function of HCMV fusogen gB

PROJECT SUMMARY/ABSTRACT
Human cytomegalovirus (HCMV) is a highly successful human pathogens that infects much of the world’s
population for life. While often asymptomatic, HCMV infections can cause severe disseminated disease in
immunocompromised patients, e.g., transplant recipients, and developmental abnormalities in neonates.
Hence, there is an urgent need for prophylactics to prevent viral transmission, especially from mother to fetus.
HCMV glycoprotein B (gB) is both a key viral penetration protein and a dominant antigen for host defense.
Unsurprisingly, gB is a component of all current HCMV vaccine candidates. However, vaccine efforts are
stymied, at least in part, by an incomplete understanding of gB-specific immune responses. Moreover, the
mechanistic contributions of gB to membrane fusion require further clarification. These gaps in our knowledge
of both gB function and antigenicity largely stem from the reliance of research on the inactive, postfusion form
of gB that cannot adequately recapitulate the active, prefusion form. We have successfully engineered
soluble HCMV gB ectodomain in a prefusion form. Here, we propose to characterize its structure,
antigenicity, and the mechanisms that control its activity. In Aim 1, we will determine the high-resolution
structures of the prefusion HCMV gB and its complexes with known neutralizing antibodies. We will also
stabilize prefusion gB for downstream applications (biochemical research and immunogen development). In
Aim 2, we will isolate and characterize prefusion-gB-specific neutralizing antibodies from HCMV-seropositive
donors. In Aim 3, we will investigate the regulatory mechanism that may restrain gB in its prefusion form. The
proposal is innovative because, to our knowledge, this is the first time the soluble prefusion form of HCMV gB
was successfully engineered. The proposal is significant because it will yield new mechanistic knowledge and
provide new reagents that could aid in the development of optimal vaccines and passive immunization
strategies against HCMV.

Public health relevance
PROJECT NARRATIVE Human cytomegalovirus (HCMV) infects the majority of the world’s population for life and can cause severe disseminated infections in immunocompromised patients, e.g., transplant recipients, and a spectrum of developmental abnormalities in neonates. The goal of this proposal is to stabilize glycoprotein gB – a molecular machine that enables HCMV entry and spread – in its biologically-active, prefusion form, characterize its structure and antigenicity, and isolate prefusion-specific neutralizing antibodies from HCMV- seropositive donors. The new reagents and knowledge resulting from the proposed work could lead to a better understanding of HCMV immune response and correlates of protection and aid in the development of optimal vaccines and passive immunization strategies against HCMV.